Development and Maintenance of the Multigenotypic Aging Mouse Colonies TASK ORDER 01

The purpose of the proposed contract is to develop, maintain and distribute animals from a standing colony of aged mice of various genotypes for use by investigators in studies of aging. Numerous investigators, supported by the NIA, other institutes, and the Veteran's Administration, use NIA mice in their research and are dependent upon NIA for access to a supply of aged mice for their research. Provision for a supply of aged mice is essential to the achievement of NIA research objectives by NIA grantees.